Targeting transdiagnostic self-regulatory factors and eating disorder pathology among adults with binge-spectrum eating disorders: A mHealth interoceptive exposure intervention

Project Summary/Abstract
Binge-spectrum eating disorders (BSED; bulimia nervosa, binge eating disorder) are associated with a
high risk of mortality and debilitating health outcomes. Yet, over half of people who receive empirically-
supported BSED treatments remain symptomatic and relapse is common. Existing treatments target symptoms
(e.g., binge eating) vs. core BSED maintenance factors, such as poor interoception (the ability to accurately
sense and connect with bodily sensations like hunger, satiety, heartbeat) and heartrate variability (HRV; a
generalized neurobiological indicator of interoception and autonomic nervous system functioning). New
treatments targeting these core biobehavioral mechanisms are urgently needed to reduce the burden of BSED.
This research will be the first to use a multiphase optimization strategy (MOST) design to develop, refine, and
assess whether a new mobile health (mHealth) interoceptive exposure intervention maps onto improvements
in interoception and eating disorder (ED) symptoms among adults with BSED. Aim 1 of the K99 study is to test
the feasibility, acceptability, and initial efficacy of targeting a generalized sensation (HRV) via a mHealth HRV
biofeedback intervention (HRV-Bio) vs. sensations often feared by people with BSED (e.g., hunger, satiety,
bloating) via a mHealth just-in-time adaptive intervention (ED-JITAI). Adults randomized to HRV-Bio (n=40) will
learn to use their HRV data (assessed via sensors: Holter monitors, smartwatches) to improve their HRV via
app-guided breathing tasks. Adults in ED-JITAI (n=40) will engage in body scans targeting feared sensations
at times when they report worse interoception than usual (i.e., more distancing from feared sensations) via
ecological momentary assessment (EMA). Data will be collected via EMA and sensors pre- and post-
treatment. It is hypothesized that: (1) The feasibility and acceptability of both interventions will be evidenced by
>75% treatment compliance and <20% attrition from pre- to post-treatment, with better rates expected for
HRV-Bio vs. ED-JITAI; (2) Improvements in binge eating, purging, self-reported interoception (assessed via
EMA), and HRV (via sensors) will be greater for ED-JITAI vs. HRV-Bio. K99 results will inform (e.g., by refining
tasks) an optimized R00 study that will (Aim 2) examine the incremental benefits of targeting both generalized
(HRV) and feared ED sensations among non-responders to initial interventions on short- and longer-term
changes in interoception and ED symptoms. Under the guidance of expert mentors at a top-10 institution with
robust resources, the applicant will work towards her career goals of launching a high-impact translational ED
research program that aims to improve the understanding of associations among transdiagnostic self-
regulatory processes (e.g., interoception) and ED symptoms, and translate this research into effective
interventions. Training will focus on improving her skills in innovative methods (sensors, MOST design),
advanced statistics, and developing mHealth interventions. This research may improve the health of adults
with high morbidity and mortality risk, in line with NIMH Strategic Goal 3 (Strive for Prevention and Cures).

Public health relevance
Project Narrative Over half of people who receive empirically-supported binge-spectrum eating disorder (i.e., bulimia nervosa, binge eating disorder) treatments remain symptomatic post-treatment and relapse is common, which is often attributed to existing treatments’ limited focus on directly targeting core biobehavioral maintenance factors for binge-spectrum eating disorders, such as poor interoception (difficulties accurately sensing and connecting with bodily sensations like hunger, satiety, and heartbeat) and heartrate variability (HRV; a generalized neurobiological indicator of interoception and autonomic nervous system functioning). To improve these suboptimal health outcomes, this research will be the first to use a multiphase optimization strategy design framework to develop, refine, and assess whether a new mobile health (mHealth) interoceptive exposure intervention that targets these core biobehavioral mechanisms (self-reported [via ecological momentary assessment] interoception, objectively-assessed [via Holter monitors and wrist-worn sensors] HRV) maps onto improvements in eating disorder symptoms and interoception among adults with binge- spectrum eating disorders. This research may reduce the growing prevalence and burden of binge- spectrum eating disorders and help improve the health of adults who have high risks of morbidity and mortality, in line with NIMH Strategic Goal 3 (Strive for Prevention and Cures).